CAR mast cell for solid tumor

Summary
Chimeric Antigen Receptor (CAR)-T cell therapies have achieved unprecedented success in treating blood
cancers that are resistant to traditional radiation or chemotherapies. However, the efficacy of CAR-T therapy to
solid tumors remains limited. Major challenges include poor infiltration of T cells into tumors, exhaustion and low
persistence of T cells under a hostile tumor environment. To tackle these problems, we aim to seek alternative
cell carriers for CAR. Mast cells present several advantages in targeting solid tumors: they reside in tumor tissues
and can live up to years. They can repetitively kill target cells without exhaustion. They also release cytokines
that can recruit other effector cells to kill cancer. In this project, we will design CARs that specifically activate
mast cells to kill solid tumors, using melanoma and colon cancer as models. Our efforts are expected to lay the
scientific foundation for a brand-new cell therapy, and provide rationales and generate reagents for moving
towards further pre-clinical and clinical studies.

Public health relevance
Project Narrative The proposed research is relevant to public health because it provides new strategies for the treatment of solid tumors. This work develops novel tools to improve the application of current chimeric antigen receptor (CAR)- based immunotherapy. In particular, a new type of cell therapy, CAR-mast cells will be developed by innovative bioengineering solutions.